BLRD Research Career Scientist Award Application

Research in the Chen lab focuses on alleviating the neurological sequelae of traumatic brain injury (TBI) and
ischemic stroke, which diminish our veterans’ quality of life. Our goals are to help identify and/or develop
pharmacologic agents that can leverage phylogenetically conserved tissue-repair mechanisms to alleviate acute
and secondary brain damage and sustain functional recovery.
TBI is a major concern for US military veterans. In TBI survivors, white matter injury is associated with long-term
functional deficits, including sensorimotor, cognitive, and psychiatric impairments. The Chen lab will continue to
develop restorative therapies that augment endogenous repair processes. Supported by VA Merit Review, we
found that the functional phenotypes of brain innate immune cells, including resident microglia and infiltrating
blood-borne macrophages, critically regulate the microenvironment in white matter and impact both white matter
injury and repair. We have recently identified salt-inducible kinase-1 (SIK1), an evolutionarily conserved protein
kinase, as a key molecular switch that governs the functional states of innate immune brain cells after TBI. Thus,
in the next four years, we will test the new hypotheses that genetic deletion or pharmacological inhibition of SIK1
improves white matter restoration and long-term TBI outcomes through dual mechanisms: 1) protecting against
early synaptic and axonal injury by inflammation-resolving microglia/macrophage responses, and 2) enhancing
chronic-stage white matter repair. Our preliminary data suggest that SIK1 inhibition not only reduces TBI-induced
sensorimotor and cognitive deficits, but also the psychiatric symptoms relevant to post-traumatic stress disorder
(PTSD). We believe that continued positive outcomes of this research will accelerate the development of novel
therapies to promote successful rehabilitation of veterans with TBI.
Stroke is a leading cause of long-term disability in elderly US veterans. Approximately 11,000 veterans are
hospitalized annually with new strokes. Although survival has increased with improvements in emergency care
and new recanalization therapy, the population with disabilities continues to climb. Optimal care of our veterans
will require therapies that not only ameliorate brain injury—but also lead to regeneration of brain tissue and
restoration of neurological function. Post-stroke immune responses have a substantial impact on the progression
of ischemic brain injury and brain recovery, but there are no clinical treatments that successfully harness the
restorative power of the immune system while also tempering inflammation-induced secondary injuries. The
reasons for this gap are multifactorial, but include a preclinical overemphasis on young adult animals, which do
not display the same pathophysiological mechanisms underlying brain ischemia as the aged. Using a clinically
relevant stroke model in 20-month old aging mice, our VA-funded research helped us make two key discoveries:
1) the remarkably reduced ability of aged brains to recover from stroke is, at least in part, due to microglial aging
and the impaired reparative functions of microglia; 2) aged microglia and post-stroke brain-repair functions of
microglia can be rejuvenated by activating the retinoid X receptor (RXR) in the aged brain. In the new VA-funded
research, we will test the ability of bexarotene, an FDA-approved RXR agonist with excellent safety profiles, to
reactivate the brain repair-enhancing functions of microglia, thereby improving long-term stroke outcomes and
functional recovery in aged animals. Thus, our long-term goals are to improve veterans’ lives after stroke and
reduce the socioeconomic burden of their disabilities.

Public health relevance
The goal of the Chen lab’s VA-funded research is to curtail the grave consequences of traumatic brain injury (TBI) and ischemic stroke on our veterans’ health and wellbeing. To meet this goal, our research team seeks to understand the regulatory role of immune cells in the progression of brain injury and functional recovery after TBI or stroke. We seek to identify the mechanisms underlying the double-edged sword of microglial activation and brain infiltration of circulating immune cells. We have successfully developed numerous strategies to harness the tissue-restorative power of immune cells while also tempering inflammation-induced secondary injuries. We will comprehensively test these strategies using state-of-the art assessments of long-term neurological functions in both male and female subjects. This molecular, cellular, and systems-level evidence will be valuable for future development of new therapies to minimize veteran disabilities, promote veteran rehabilitation, and improve quality of life after TBI or stroke.